Dynamic Treatment Regimes for Personalized Opioid Use Disorder Care

PROJECT SUMMARY
This Mentored Research Scientist Development Award (K01) application is submitted by Jason Brian Gibbons,
PhD, an assistant professor in the Department of Health Systems, Management, and Policy at the University of
Colorado Anschutz Medical Campus. Dr. Gibbons's long-term goal is to improve the quality of care for
patients with opioid use disorders (OUD) and reduce overdose deaths. Over the past few years, Dr.
Gibbons has focused his research on studying the effectiveness of OUD treatment and policies and programs
aimed at expanding OUD treatment service access, use, and adherence. As part of this proposal, Dr. Gibbons
aims to obtain rigorous training in novel machine learning-based dynamic treatment regime methods
(DTRs) and optimization trial designs to study the dynamic and heterogeneous nature of OUD severity and
treatment response with the ultimate goal of using study findings to optimize OUD treatment delivery. He
proposes a 5-year program of career development and mentored research to accomplish this research
objective. Dr. Gibbons will work with an interdisciplinary team of mentors from the University of Colorado
Anschutz Medical Campus, Brigham and Women's Hospital, and the University of Michigan, who have
international reputations in the areas of his proposed training. The overarching objective of his proposal is to
develop dynamic, personalized treatment recommendations using machine learning-based DTRs. DTRs can
use high-dimensional data on patient's medical and social characteristics to assess the relationship between
factors and treatment responses over time. The DTR then uses these relationships to craft optimal treatment
decision rules. The DTRs will incorporate extensive health records from a national Behavioral Health Care
Services provider, Discovery Behavioral Health, and linked all-payer claims and death records. Once the
treatment decision rules have been constructed using several DTRs, a single model will be identified as “best-
performing” based on its ability to generate decision rules that minimize patient risk of opioid overdose and
hospitalization. A pilot hybrid factorial sequential multiple assignment randomized trial (SMART) will then be
conducted to assess the acceptability and feasibility of a future full-scale trial (R01) that will evaluate the
effectiveness of the generated treatment decision rules from the best-performing DTR. This research can
potentially mark a paradigm shift in OUD treatment by moving towards individualized, data-driven treatment
and aligns with NIDA's broader public health goals and strategic priorities. This research and Dr. Gibbons's
planned training activities will prepare him to develop and test adaptive treatment strategies that may be able
to improve OUD treatment outcomes. Training and research from this proposal will also be relevant to his
interests in optimizing treatment for other chronic substance use and mental health disorders. Finally, the
research and training will give Dr. Gibbons the solid foundation he needs to become an independent
investigator and future leader in mental health and substance use disorder treatment quality research.

Public health relevance
PROJECT NARRATIVE The proposed research aims to improve opioid use disorder (OUD) treatment quality by using machine learning dynamic treatment regime models (DTRs) that measure the time-varying relationship between treatment and patient-reported OUD severity to identify optimal practice patterns. Several DTR models will be estimated and compared in terms of their ability to identify treatment decision rules that minimize patient risk of fatal and non-fatal opioid overdose, and a pilot hybrid factorial sequential multiple assignment trial (SMART) will be conducted to assess the feasibility and acceptability of a full-scale trial that will evaluate the effectiveness of the generated treatment decision rules. The research aligns with NIDA's strategic goals by promising significant advancements in OUD treatment quality and the broader field of personalized medicine for chronic substance use disorders.